Graduate Training Program for Magnetic Resonance Imaging

Abstract
This T32 proposal entitled, “Graduate Training Program in Magnetic Resonance Imaging” (TPMRI), seeks
funding to support predoctoral students (3 trainees in year 1-2, 5 trainees in years 3-5) in Biomedical Engineering
(BME) at Northwestern University (NU). Predoctoral students will be appointed to the TPMRI for a duration of 2
years after they have completed all required coursework and passed their Qualifying Exam. The program will be
multi-disciplinary in nature, covering complementary imaging science topics for broad training in translational
MRI projects. The objective is for students to obtain in-depth understanding of MR physics and engineering
principles and clinical applications based on participation in innovative MR research with a specific emphasis on
PhD-MD interactions to enable clinical translational research.
The strengths of the TPMRI program lie in the breadth of MR research, state-of-the-art instrumentation
capabilities, and strong industry ties. The training program is characterized by a `hands-on' training approach
that will take advantage of the excellent research infrastructure at Northwestern which provides trainees access
to state-of-the-art MRI systems dedicated to imaging research at several core facilities throughout the university
campus. Key elements of the TPMRI include dedicated MRI course work, clinical exposure rotations, optional
medical physics rotations, MRI hardware and safety training, grant writing requirement and mock study section,
as well as rigorous evaluation and support for underrepresented minority (URM) trainees.
Established Interactions between BME and clinical researchers create a unique environment for training students
for clinical translational research. NU has a long history of successful collaborations among TPMRI preceptors,
particularly between MR physicists/bioengineers, investigators in Radiology, and physicians/scientists from
clinical departments. This infrastructure will provide students with easy access to clinical MRI systems with
dedicated research time to develop and test new imaging methods. In addition, the on-site training and research
will facilitate interactions between BME students, clinicians and physician scientists, and industry representatives
who utilize these MRI systems to conduct clinical translational research studies.

Public health relevance
Narrative Diagnostic imaging with Magnetic Resonance Imaging (MRI) is an emerging field with ever expanding capabilities and roles in both basic medical research and clinical applications. This proposal is a request for funding of an institutional combined predoctoral Training Program for MRI in Biomedical Engineering at Northwestern. Our goal is to train the next generation of scientists for a medical imaging career in academia, hospital, or industry.